Impact of HIV and toxic metals exposure on neurodevelopment at school age

ABSTRACT
There are over 16 million children exposed to HIV (CHEU), the majority of whom reside in East and Southern
Africa (ESA). This population is expected to grow as more women living with HIV access services to prevent
vertical transmission of HIV. Evidence points to poorer neurodevelopment outcomes among CHEU compared to
HIV unexposed children (CHU). Exposure to neurotoxic metals and pesticides also play a role in pathogenesis
and may synergistically affect neurocognitive outcomes among CHEU. Studies that determine the combined
impact of HIV and environmental exposures on child outcomes are lacking, despite the high prevalence
of these exposures in ESA. Understanding whether HIV exposure impacts school-age outcomes has been
challenged by changing ART regimens as the epidemic has evolved, and lack of assessment of multiple risk
factors including environmental exposures.
We propose to extend follow-up for a well characterized large cohort (n=2,000) of CHEU/CHU, enrolled
at age 6 weeks and followed up to 3 years, to study neurodevelopmental outcomes at school age (age
5-8) and the impact of HIV and environmental exposures on neurodevelopmental outcomes. We will use
exposure, biological samples, and neurodevelopmental data available from the first 3 years of life. The majority
of CHEU were exposed to maternal dolutegravir-based ART (77%) and 85% started ART pre-conception. In Aim
1, using stored samples and neurodevelopmental data collected in the first 3 years of life, we will test for Pb
levels and determine the association between early Pb exposure and neurodevelopment and determine whether
HIV modified the impact of Pb exposure. In Aim 2, we will re-enroll 1,000 children and follow them up to age 8
years to determine the longer-term impact of HIV and Pb exposure on neurocognition and motor function. In Aim
3, we will assess concentrations of neurotoxic heavy metal exposures and pesticides using novel biological
samples (nails and hair). Pb and heavy metal assays will be conducted using x-ray fluorescence (XRF) and we
will assess associations between these exposures, HIV exposure, and neurocognition.
This proposal leverages a large unique longitudinal mother-child cohort of CHEU and CHU, with
comprehensive neurodevelopmental assessments and analysis at scale, to comprehensively understand
burden, mechanism and neurodevelopmental outcomes in CHEU. We will utilize novel biological samples and
efficient technology to assess environmental exposures contributing evidence on inform use of these methods
to assess environmental exposures in ESA and globally. We will work with national and global health leaders,
community members, and policymakers to discuss study findings, implications, and next steps.

Public health relevance
NARRATIVE Globally there is an increasing number of children who are exposed to HIV but remain uninfected, and most of these children live in Eastern and Southern Africa where exposure to environmental toxins (lead, heavy metals and pesticides) is high. We propose to extend evaluation of children in an existing cohort in Kenya followed from infancy to age 3 years to determine the impact of HIV exposure and environmental toxin exposure in early life (age 0-3) at school age (age 5-8 years). We plan to re-enroll 1000 children and work with national stakeholders to review findings to inform efforts to improve child health outcomes.